New Catalytic Systems for Stereoselective C-H Amination

PROJECT SUMMARY/ABSTRACT New Catalytic Systems for Stereoselective C–H Amination Nitrogen-containing compounds are of central importance in biology and medicine. The development of synthetic methodologies that allow for selective conversion of omnipresent C–H bonds into valuable amine functional groups promises to transform the art and practice of organic synthesis and should lead to many new applications. Among different approaches, catalytic C–H amination via nitrene insertion represents one of the most important classes of chemical transformations. This type of catalytic nitrene transfer process provides a direct and general approach for the functionalization of C–H bonds in organic compounds through stereoselective C–N bond formation. It serves as a useful tool for the design and synthesis of biologically and pharmaceutically important chiral amine molecules. While considerable progress has been made for C–H amination by existing catalytic systems with the widely-used reagent PhI=NTs and related iminoiodane derivatives as nitrene sources, important challenges remain in the field that validate the need to identify more effective nitrene sources in conjunction with the development of fundamentally new metal catalysts for C–H amination. Guided by the concept of metalloradical catalysis (MRC), this research project is directed toward the development of new catalytic systems for stereoselective C–H amination reactions. As stable metalloradicals, cobalt(II) complexes of porphyrins [Co(Por)] have been shown to function as a unique class of catalysts for C–H amination through stepwise radical mechanism. Supported by porphyrin ligands bearing amide functionalities, the Co(II)-based MRC has been shown to be particularly effective in activating various azides for radical amination of different types of C–H bonds, leading to formation of amine derivative with effective control of reactivity and selectivity. In this new proposal, we will focus on the utilization of cobalt(II) complexes of chiral porphyrins [Co(II)(Por*)] as chiral metalloradical catalysts to advance the enantioselective C–H amination reactions for stereoselective synthesis of optically active amine derivatives, including amino acids, diamines, amino alcohols and N-heterocycles. We hope these studies will ultimately lead to the development of Co(II)-based new catalytic systems for stereoselective C–H amination reactions that can be generally applied toward practical synthesis of biologically important nitrogen-containing natural products and pharmaceutically interesting compounds.

Public health relevance
PROJECT NARRATIVE New Catalytic Systems for Stereoselective C–H Amination The development of general and efficient chemical reactions provides the necessary tools for the design and synthesis of biologically and pharmaceutically important molecules. There has been a growing emphasis on developing practical methodologies for the synthesis of enantiomerically pure compounds, since enantiomeric isomers often exhibit different biological activities. Among different approaches for preparing chiral non-racemic molecules, transition metal-based asymmetric catalysis offers promise for the development of cost-effective and environmentally benign methods.